Mechanisms of messenger RNA splicing and RNA processing regulation

PROJECT SUMMARY
Messenger RNA splicing is carried out by a large macromolecular machine, the spliceosome,
which undergoes dramatic rearrangements as it assembles onto a pre-messenger RNA. Our
understanding of this elegant ribonucleoprotein machine has advanced significantly with the
availability of cryoEM structures and an extensive “parts list” of splicing components. However, many
questions remain about how spliceosome assembly takes place in the cell, where the spliceosome
machinery assembles onto a nascent transcript that is being actively transcribed from a chromatin
template, i.e. co-transcriptionally. Moreover, assembly of the spliceosome and splicing catalysis is
tightly regulated and, in fact, there are widespread examples across eukaryotes of intron retention.
Nonetheless, the regulatory consequences of this phenomenon remain obscure. Guided by strong
preliminary data, we explore both of these outstanding challenges and address the following
questions: (1) How does chromatin influence spliceosome assembly and vice versa, i.e. how does
co-transcriptional spliceosome assembly affect the state of the chromatin? (2) How does intron
retention contribute to gene regulation? (3) How does mis-regulation of intron accumulation lead to
cellular toxicity and disease?

Public health relevance
PROJECT NARRATIVE Proper expression of information in genes is absolutely critical for correct cellular function; defects in any of the reactions involved in gene expression can have catastrophic consequences for the cell. Genes contain long stretches of interrupting information (introns) that must be removed by the cellular machinery in order for that information to be properly expressed, a process called RNA splicing; mutations that cause defects in these mechanisms are a leading cause of a variety of human diseases—from neurodegeneration and blindness to all known cancers. The focus of our work is to understand the molecular details underlying RNA splicing and its regulation, as this is a crucial step toward understanding the etiology of human diseases and, ultimately, for developing tools to treat them.